FASEB SRC: The Genetic Recombination and Genome Rearrangements

Project Summary/Abstract
This application seeks partial support for the Federation of American Societies of Experimental Biology
(FASEB) Summer Research Conference (SRC) on Genetic Recombination and Genome Rearrangements, to
be held August 14-19, 2022 in Steamboat Springs, Colorado. This will be the 19th in a series of highly
successful biennial conferences devoted to these topics. This conference aims to bring together diverse
investigators studying broad aspects of genetic recombination, in a range of biological systems and using
different experimental approaches. Presentations will describe cutting-edge unpublished work on timely
questions in the field and will foster discussions among diverse groups of participants at all career stages. This
FASEB conference will provide unique opportunities for the open exchange of data and technological
innovations that can be assimilated and exploited across the entire field. The topics of Genetic Recombination
and Genome Rearrangements cover many areas directly relevant for cancer. Homologous recombination is
essential to limit genome rearrangements that promote the oncogenic state, and many factors involved
recombination and its regulation are tumor suppressors. Hence, studies of recombination are paramount to
understanding cancer etiology, to developing much needed biomarkers, and to identifying new tumor
suppressors. In addition, systemic or localized DNA damage induced by chemotherapy or radiation remains a
major mode of cancer treatment. Recombination is a major pathway for the repair of the DNA double-strand
breaks and interstrand crosslinks that result from these therapies. Therefore, understanding the regulation and
mechanism of recombination will inform novel and more efficacious strategies of cancer therapy. The FASEB
conference brings together investigators from diverse disciplines, including biochemistry, biophysics, genetics,
genomics, and cell biology, that cover all aspects of recombination. Key topics to be covered in 2022 include (i)
the molecular mechanisms that underpin each step in the recombination reaction, (ii) meiotic recombination,
(iii) telomere dynamics, (iv) genome rearrangements that occur during the development of cancer, (v) the
relationships between RNA metabolism and recombination, (vi) repair of replicated-associated DNA lesions,
(vii) the influence of chromatin structure on recombination, and (viii) DNA damage signaling. Special emphasis
on these topics is reflected in our initial speaker invitations. In addition, 21 plenary session talks (about one-
third of the total) will be selected from abstracts with an emphasis on late-breaking advances from
underrepresented and early-stage scientists. A number of innovations to the conference plan and program aim
to further enhance participation, interaction, exchange and discussion among a diverse group of participants;
and increase the exposure of younger scientists. In sum, the FASEB SRC on Genetic Recombination and
Genome Rearrangements remains the most important conference on a topic of the highest interest and
importance to cancer research and the scientific community.

Public health relevance
Project Narrative The FASEB conference on Genetic Recombination and Genome Rearrangements brings together the world’s leading researchers investigating the mechanisms and regulation of genetic recombination. This field encompasses several topics directly relevant for cancer and its treatment. Therefore, a mechanistic understanding of these processes is paramount for an improved understanding of cancer etiology, for the identification of critical biomarkers, and for developing novel strategies of cancer treatment that are more efficacious and minimize side effects.